Biomedical Informatics and Data Science Training Program (BIDS-TP)

This is a new application to support a novel Biomedical Informatics and Data Science Training Program
(BIDS-TP) at the University of Michigan (UM). The overarching goal of the BIDS-TP is to train a cadre of data-
savvy, computationally-skilled, and highly-motivated biomedical scholars in an intellectually-stimulating
environment using an effective competency-based curriculum. To enhance their scientific, clinical, and
translational abilities, all BIDS-TP students will be trained in collecting, managing, processing, interrogating,
and analyzing large amounts of complex high-dimensional biomedical information with rigor and transparency.
Throughout the 5-year funding cycle, the Program will annually support 12 Fellows (6-Year 1 and 6-
Year 2). Program participants will also include additional 10 Trainees that are fully-engaged, but funded by
other mechanisms. The BIDS-TP program represents a unique collaboration between the UM’s Department of
Computational Medicine and Bioinformatics (DCMB) and the Michigan Institute for Data Science (MIDAS). This
partnership will provide immersive synergistic activities, translational education, transdisciplinary research
projects, co-mentoring, and career development for all BIDS-TP Fellows and Trainees. Feeder graduate
programs with eligible pre-doctoral trainees include DCMB and MIDAS doctoral students from engineering,
mathematics, statistics, public health, and information sciences. Thirty-six UM faculty members from 6 UM
Schools and Colleges will provide breadth and depth of scholarly research, co-mentoring, career coaching, and
student-specific curriculum development. The BIDS-TP curriculum requires all trainees to complete the add-on
graduate data science certificate program, and to actively participate in BIDS-TP workshops, seminars, and
short-courses on biomedical informatics, health analytics, and computational data science.
Capitalizing on the extensive database of successful DCMB, MIDAS, and Rackham Graduate School
alumni, the Program will support professional networking, practical career mentorship, employment and career
opportunities to promote the next generation of biomedical and health data science leaders. All scholars will be
encouraged to focus their energy to design rigorous experiments, and develop effective techniques to tackle
critical challenges, address unmet needs, and bridge scientific knowledge gaps. The strong, interdisciplinary,
and trainee-mentor tailored curriculum plans will facilitate trainee’s growth, employability, and positioning to
contribute to the NIH mission to discover, model, understand and treat complex human disorders. BIDS-TP will
increase the capacity, ability, and efficacy of the US workforce to address known and unexpected biomedical,
health and environmental challenges using advanced bioinformatics and data science techniques. As a
premiere global institution, UM is dedicated to research, education and training of biomedical and data science
graduate students. There are a number of complementary and synergistic UM activities that will support the
BIDS-TP trainees and mentors in fertilizing interdisciplinary, collaborative, and cutting edge research.

Public health relevance
BIDS-TP: Project Narrative The focus of the University of Michigan (UM) Biomedical Informatics and Data Science Training Program (BIDS-TP) is on developing a unique environment and an effective curriculum to train a cadre of data-savvy, computationally-skilled, and highly-motivated biomedical scholars. All BIDS-TP students will be trained in collecting, managing, processing, interrogating, and analyzing large amounts of complex high-dimensional biomedical information, as well as scientific rigor, validity, and reproducibility. BIDS-TP will increase the capacity, ability, and efficacy of the US workforce to address known and unexpected biomedical, health and environmental challenges using advanced bioinformatics and data science techniques.